Intubation with Sedation Only to Prevent Hypoxemia during Emergency Tracheal Intubation of Critically Ill Adults: A Randomized Clinical Trial

ABSTRACT
Dr. Stephanie DeMasi is an academic physician-scientist in the Department of Emergency Medicine at
Vanderbilt University Medical Center. Her focus is improving care for patients receiving time-sensitive
interventions in the emergency department (ED) and intensive care unit (ICU). To achieve her long-term career
goal of becoming an expert acute care clinical trialist, her career development goals are to [1] learn rigorous
pragmatic randomized trial design, [2] become an expert in exception from informed consent (EFIC), waiver,
and written informed consent processes, [3] develop expertise in the collection and analysis of long-term
functional and psychological outcomes after critical illness, and [4] build leadership skills to effectively lead
multicenter randomized trials. Research Proposal Summary: Each year in the United States, millions of adults
undergo emergency tracheal intubation (placement of a breathing tube). Nearly one quarter of patients
undergoing tracheal intubation in an ED or ICU experience hypoxemia, which more than doubles the risk of
death. The most common approach to intubation of critically ill adults involves the administration of a sedative
followed by neuromuscular blockade (paralysis). The alternative approach of using only sedation for intubation
has not been widely used historically because neuromuscular blockade was often needed for the person doing
the intubation to see the vocal cords. In the current era, with video laryngoscopy and other advanced
techniques, the patient’s muscles do not need to be as relaxed for the vocal cords to be easily visible on the
video screen. Therefore, patients may not need to be paralyzed during intubation to achieve adequate
visualization of the vocal cords. Avoiding neuromuscular blockade would allow patients to breathe
spontaneously during intubation, potentially preventing hypoxemia. No randomized trial has ever compared
tracheal intubation using only sedation vs using sedation and neuromuscular blockade among critically ill
adults. This career development award application proposes to leverage our group’s research infrastructure to
conduct the INtubation with Sedation Only to Preserve Independent Respiratory Effort (INSPIRE) trial, a single-
center pragmatic randomized trial comparing the effect of emergency intubation using sedation only versus
sedation plus neuromuscular blockade among 228 critically ill adults undergoing emergency intubation on the
incidence of hypoxemia (Aim 1a), failure to intubate on the first attempt (Aim 1b), incidence of awake
immobility (Aim 2a), and symptoms of PTSD at 90 days (Aim 2b). This application proposes a career
development program that will (1) examine a fundamental treatment received by adults with acute respiratory
failure, (2) provide the mentored learning for Dr. DeMasi to become a leader in the design and conduct of
randomized trials in emergency care, and (3) ideally position Dr. DeMasi to lead subsequent multicenter trials
of emergency interventions to improve care and outcomes of critically ill adults going forward.

Public health relevance
NARRATIVE Millions of critically ill adults receive a neuromuscular blockade medicine (paralytic) during emergency intubation each year. The use of neuromuscular blockade is intended to make it easier to see the vocal cords and place the breathing tube, however it is unknown in the era of video laryngoscopy if this medicine is required for every emergency intubation, or if the risks of giving this medicine outweigh the potential benefit. The INtubation with Sedation Only to Preserve Independent Respiratory Effort (INSPIRE) trial will compare the effect of intubation with sedation only and intubation with sedation plus neuromuscular blockade on hypoxemia during intubation and failure to intubate on the first attempt.